IUSM TREAT-AD Center

PROJECT SUMMARY/ABSTRACT
The strategic goal of the Indiana University School of Medicine Purdue University TaRget Enablement to
Accelerate Therapy Development for Alzheimer's Disease (IUSM-Purdue TREAT-AD) Center is to integrate
sophisticated disease biology and drug discovery capabilities to create Target Enabling Packages (TEPs) for the
study of emerging Alzheimer's disease hypotheses (beyond amyloid beta) and create the foundation for new
classes of therapeutics. The IUSM-Purdue TREAT-AD Center has established itself as a strategic and
operational partner for NIA supported consortia. By design, we provide drug discovery capability to bridge the
new disease target hypothesis work of AMP-AD with well characterized molecular entities for evaluation in
cellular and in vivo models based on human pathology, genetics, and translational biomarkers. To accomplish
this mission, we have assembled a world-class team of scientists and capabilities from IUSM, Purdue University,
University of Pittsburgh School of Medicine, and the Indiana Biosciences Research Institute (IBRI). This team
has considerable expertise in AD biology, pharma drug discovery and development, and in the core discovery
technologies that drive the Center's contributions, deliverables and achievement of milestones. A key advantage
and differentiated strength of our Center is the primary scientific coordination and administration through IUSM.
This capability concentrates a strong and long-standing commitment to neurodegenerative research through co-
presence with the NIA-supported Indiana Alzheimer's Disease Center under the direction of Dr. Andy Saykin,
the MODEL-AD consortium under the direction of Dr. Bruce Lamb, and the Longitudinal Early Onset Alzheimer's
Disease (LEAD) study under the direction of Dr. Liana Apostolova. Our aims are (1) Create a dynamic portfolio
of well characterized neuroinflammation AD drug discovery targets representing novel intervention hypotheses
that capitalizes on significant investments in basic research and emerging disease understanding; (2) Perform
target validation and enablement studies to prioritize opportunities for therapeutic discovery; (3) Create high
quality and well characterized molecules for prioritized targets that meet rigorous milestone criteria and are
valued opportunities for further translational investment; (4) Enable global researchers with open access data
and Target Enablement Packages (TEPs) to expand on the work of the TREAT-AD Consortium. Collectively,
these aims will support the translation of new molecular entities into the clinic that will reduce neurodegeneration
and improve cognition, thus advancing the NIH/NIA mission to develop novel therapies for AD.

Public health relevance
PROJECT NARRATIVE Alzheimer's Disease (AD) is a major cause of death and disability in the United States. The Indiana University School of Medicine Purdue University TaRget Enablement to Accelerate Therapy Development for Alzheimer's Disease (IUSM-Purdue TREAT-AD) Center seeks to identify and validate novel biological targets emerging from the NIA/NIH AMP-AD initiative that are enabled for drug discovery and translational studies in patients with AD. Importantly, the Center will share data, methods and enabling science through the AD Knowledge portal, an open access platform that benefits investigators and associated research initiatives worldwide.